Spectroscopic Characterization of Enzymatic Intermediates with FeS Clusters

Project Summary
Iron-sulfur clusters are found in all kingdoms of life, used by nature for electron transfer, for performing
highly specific organometallic chemistry in the biosynthesis of natural products, and for catalysis of challenging
redox transformations of small molecules. Elucidating the mechanisms of these reactions is critical for
understanding the fundamental biochemistry of these enzymes, which could inspire future drug and (bio)catalyst
design. Spectroscopic techniques to probe enzymatic mechanisms and reactive intermediates under
physiological conditions and in nondestructive manners are desired but can be difficult to achieve. Advanced
electron paramagnetic resonance (EPR) and parahydrogen induced polarization (PHIP) nuclear magnetic
resonance (NMR) techniques, along with appropriate isotopic labeling, will be utilized to study the mechanisms
and reactive intermediates of several enzymes containing unique iron-sulfur clusters.
Herein, three systems suitable for these techniques are discussed. The last step of biotin synthesis is
catalyzed by BioB, where a radical S-adenosyl-L-methionine enzyme sacrificially uses a [2Fe-2S] auxiliary
cluster for S-atom transfer. A new, “Type II” class of BioB has been recently discovered, utilizing an uncommon
[4Fe-5S] auxiliary cluster that may not be destroyed during turnover, though the mechanism is unestablished.
Advanced EPR studies with appropriate isotopic labeling will help characterize the paramagnetic intermediates,
providing hypotheses for their structures in the absence of crystallographic data. NMR hyperpolarization
techniques (PHIP) will be employed to study the H-cluster of [FeFe]-hydrogenase, where the Britt group’s abilities
to isotope-edit the 13C, 15N, and 57Fe nuclei of the diiron subcluster is hypothesized to allow for polarization
transfer from parahydrogen, demonstrating the utility of PHIP in studying enzymatic mechanisms. Signal
enhancement will overcome NMR’s inherent low sensitivity and allow for site-specific characterization of the
structure and dynamics of the H-cluster under physiological conditions. The FeMo cofocator (FeMoco) of
nitrogenase uses “green” sources of H2 in the form of H+ and e− to catalyze the difficult reduction of nitrogen into
ammonia, which is used as fertilizer. Despite herculean efforts to understand this mechanism, much of it remains
unestablished; the structure of the substrate-bound species is widely debated, and even less is known about the
mechanism after substrate binding. FeMoco also generates one equivalent of H2 per turnover, and the H2 release
is thought to relate to N2 binding in a reversible fashion. Thus, it is hypothesized PHIP is a technique well suited
for probing this mechanistic step. Polarization transfer to other magnetic nuclei including 15N is expected to add
direct evidence regarding the binding mode of substrate in FeMoco. Alternative strategies involving the design
of polarization transfer catalysts that can produce hyperpolarized nitrogenase substrates are also proposed.
Expected outcomes of this research will add to the rich field of iron-sulfur biochemistry and provide new
spectroscopic tools for studying enzymatic mechanisms under physiological conditions.

Public health relevance
Project Narrative Advanced electron paramagnetic resonance (EPR) and parahydrogen induced polarization (PHIP) nuclear magnetic resonance (NMR) techniques will be employed to study the mechanisms of biotin synthesis by BioB, reversible dihydrogen evolution by [FeFe]-hydrogenase, and dinitrogen reduction by nitrogenase. Understanding how nature utilizes these unique iron-sulfur active sites to control reactive intermediates and perform difficult redox transformations is important, possibly inspiring future drug and (bio)catalyst design for pharmaceutically and industrially relevant chemicals that impact human health. Technique development of nondestructive and noninvasive spectroscopic methods to study these transformations under physiological conditions will greatly advance the field of enzyme mechanistic research.